The Potential Role of Firboblast Activation Protein as a Natural Killer Cell Immune Checkpoint in Pancreatic Cancer

PROJECT SUMMARY
Immunotherapy has been largely ineffective in pancreatic cancer, partially due to the surrounding dense stromal
fibrosis which creates an immunosuppressive microenvironment. The main cellular component of this fibrosis,
pancreatic stellate cells (PSCs), are marked by elevated expression of fibroblast activation protein (FAP). FAP
is a type II transmembrane serine protease that is minimally expressed in normal pancreas, however, in
pancreatic cancer FAP is overexpressed in 90% of lesions and is associated with worse clinical outcomes. Here
we use a novel in vitro co-culturing system that utilizes primary donor-derived PSCs and a human natural killer
(NK) cell line, NK92, to assess the relationship between PSCs and NK cells. We tested the ability of NK cells to
kill PSCs and monitored for FAP expression and markers of activation. We also assessed the effect of FAP
inhibition on NK cell activity in vitro and pancreatic tumor clearance in vivo. We found that NK cells are activated
by and kill PSCs, potentially via NK cell surface receptor NKG2D recognition of MICA/B on PSCs. Upon direct
contact with PSCs, PSCs downregulate FAP, however, NK cells upregulate FAP. This is the first-time NK cells
have been shown to produce FAP and that induction of FAP is mediated by cell-to-cell contact. Furthermore,
FAP expression by NK cells is associated with an inactivate phenotype. FAP inhibition enhanced NK killing of
PSCs in vitro and enhanced pancreatic tumor clearance in vivo. The anti-tumor activity of FAP inhibition was
enhanced by addition of anti-PD-1 therapy. Based on these findings, I hypothesize that FAP functions as an NK
cell immune checkpoint. FAP is expressed in NK cells after activation to attenuate cytotoxicity and can be
inhibited to enhance anti-tumor immunity. To test this hypothesis, I aim to determine mechanisms of FAP
induction in NK cells (Aim 1), assess the clinical relevance of these findings (Aim 1A and 1D) and manipulate
FAP activity to enhance in vitro and in vivo anti-tumor immune responses (Aim 2). Successful completion of
these aims will identify factors that regulate FAP expression and further our understanding of how FAP regulates
the immune response. These findings will fill the gap in knowledge surrounding regulators of FAP expression
and provide new approaches to enhance anti-tumor immune activity.

Public health relevance
PROJECT NARRATIVE Immunotherapy has been largely unsuccessful in pancreatic cancer, in part because of the thick scar tissue that often surrounds the tumor. This project aims to better understand the relationship between components of this scar tissue and anti-cancer immune cells. Successful completion of this project will fill current gaps in scientific knowledge and potentially identify new immunotherapies that would prolong life for pancreatic cancer patients.